A Randomized Clinical Trial Examining Intranasal Oxytocin Augmentation of Brief Couples Therapy for Veterans with PTSD

Background and Significance: Posttraumatic stress disorder (PTSD) impacts both individual and relationship
functioning. In romantic relationships, PTSD can impact both partners, causing disruption within the relationship
that can in turn worsen PTSD symptomology. Poor relationship functioning places Veterans at greater risk for
other negative outcomes such as suicide, homelessness and substance use disorders. Veterans seeking
treatment for PTSD often want to improve their intimate relationships and express the desire to involve close
others in treatment. Treatment outcomes are in fact enhanced when both partners engage in treatment together.
One treatment option for Veterans and their partners is brief Cognitive-Behavioral Conjoint Therapy (bCBCT), a
trauma focused 8-session psychotherapy for PTSD that is delivered in a dyadic format to an individual with PTSD
and a loved one—typically an intimate partner. This intervention has been rolled out in the VA and is consistently
efficacious in improving PTSD, however the effects of bCBCT on relationship functioning are less robust with
small effect sizes, especially among Veterans. Novel pharmacological augmentation strategies that
simultaneously target mechanisms of PTSD and relationship functioning may increase the potency and impact
of bCBCT. Intranasal oxytocin is one such novel agent, as it influences multiple processes relevant to PTSD
recovery, such as fear extinction, and relationship functioning, including but not limited to trust, empathy, and
positive communication. Intranasal oxytocin is therefore ideally suited to enhance the effects of bCBCT. The
goal of this proposal is to examine the efficacy of bCBCT augmented with intranasal oxytocin for improving
Veterans' PTSD symptoms and relationship satisfaction among both Veterans and their intimate partners. It is
hypothesized that the bCBCT + oxytocin condition will outperform bCBCT + placebo with respect to Veterans'
PTSD symptoms and both Veterans' and partners' relationship satisfaction. Additionally, this study will explore
the impact of intranasal oxytocin on Veterans' psychosocial functioning and potential mechanisms of action (i.e.,
communication skills, empathy, and trust).
Methods: This study will recruit 120 couples from the VA San Diego Healthcare System for a placebo-controlled
four-year randomized clinical trial. Eligible couples will consist of a Veteran with PTSD and the Veteran's intimate
partner. Veterans will self-administer 40 international units of intranasal oxytocin (n = 60 dyads) or placebo (n =
60 dyads) 30 minutes before each of the 8 bCBCT sessions. PTSD, relationship satisfaction, psychosocial
functioning, and potential mechanisms of action (communication skills, empathy, and trust) will be assessed at
baseline, mid-treatment, post-treatment, 3-month, and 6-month follow-up.
Impacts on Veteran Health Care: This proposal directly addresses the VA priority of advancing innovations in
VHA health care, as well as
the need for interventions that bridge the knowledge-translation gap between existing
evidence-based treatments and increasing their efficacy for Veterans.
Results of the proposed evaluation would
contribute to the VA directive of providing family-based care to all Veterans, as well as address the VA priority
of advancing innovations in healthcare. This investigation of bCBCT augmented with intranasal oxytocin could
yield immediate clinical impact and greatly enhance the delivery of evidence-based care for Veterans and their
partners.

Public health relevance
Posttraumatic stress disorder (PTSD) disrupts romantic relationships and other aspects of psychosocial functioning, which can worsen Veterans' PTSD symptomatology and interfere with their long-term recovery. The proposed four-year study aims to reduce PTSD symptoms and improve relationship functioning among Veterans with PTSD. Dr. Morland (PI) and Dr. Sippel (PI) propose to examine the effects of couples' therapy for PTSD augmented with intranasal oxytocin, a neurohormone that affects mechanisms of trauma recovery and social behavior, on Veterans' PTSD and psychosocial functioning, and both Veterans' and partners' relationship satisfaction. The study will also explore the impact of intranasal oxytocin on potential mechanisms of action. Brief Cognitive-Behavioral Conjoint Therapy will be combined with intranasal oxytocin or placebo condition to determine the efficacy of the oxytocin augmentation, thereby advancing knowledge of strategies for improving Veterans' psychosocial functioning by improving their personal relationships.